CSHL 2022 Microbiome Conference

MICROBIOME Conference
October 25 – 29, 2022
The third installment of the international Microbiome conference at Cold Spring Harbor
Laboratory will include the latest research exploring the etiology and treatment of a wide-range
of microbe-associated diseases, integrating the disciplines of clinical research, microbiology,
immunology, ecology, bioinformatics and genomics. From the prior two meetings in 2019 (in-
person) and 2020 (virtual due to COVID), it was clear that the CSHL Microbiome meeting offers
a unique forum where a wide variety of disciplines come together to catalyze new ideas and
integrate approaches focused on the varied roles microbiomes play in human health. The
explicitly broad definition of microbiomes targeted by this conference will allow for continued
mutual fertilization of ideas, techniques and theories developed by researchers active in clinical,
ecological and evolutionary lines of research. As well as bringing established leaders as
speakers, this meeting will focus on young investigators and trainees to facilitate the scientific
interactions necessary to grow this field and develop novel clinical and experimental
approaches, diagnostics and therapies. The meeting will provide an in-depth focus on both
experimental and computational approaches that are being used to elucidate the mechanisms
of microbial community assembly, inflammatory, immunologic and infectious diseases. We will
also explore novel roles for the microbiome in drug response. Microbiome studies that are
featured in the oral presentations will include bacterial, fungal and viral associated disease, and
include microbe-microbe interactions. Oral and poster sessions will focus on major themes of
microbiome and the host response, including; Ecology of the Microbiome; Evolution and the
Microbiome; Health; Nutrition; Environment and the Microbiome; Animal Models; Reductionist
Models; & Technology. The meeting will include two plenary keynote speakers invited to give
longer talks. The oral sessions will begin with two invited talks from established leaders in the
field, followed by 6 shorter talks chosen from submitted abstracts. The inclusion of poster
sessions as well as the allotment of ample time for questions following each talk will encourage
extensive discussion between the participants. The meeting will be small enough (250 - 350
scientists attending in-person, with an additional virtual audience to broaden access) to facilitate
these interactions, yet large enough to allow for oral presentations from younger investigators
and those with novel perspectives. The integration of a wide variety of aspects of microbiome
research will nucleate new interdisciplinary interactions that will drive this innovative
translational field. This meeting will be distinct in the opportunities for young investigators to
present their work and the coalescence of computational, experimental and clinical disciplines.

Public health relevance
MICROBIOME Conference October 25-29, 2022 PROJECT NARRATIVE Scientific studies have transformed our concept of microbes (bacteria, fungi, viruses, archaea). Whereas we used to conceive of most microbes as disease-causing enemies, we now understand that microbes are essential for promoting health and might also contribute to ameliorating disease. A growing body of research seeks to uncover how microbes interact with each other in multispecies communities and cohabitate with their multicellular human hosts. If we better understand how microbial communities interact, through modeling these interactions and dissecting the mechanisms at this interface, we will open the door to therapies that prevent or correct microbial community dysfunction to promote health and treat disease. The third installment of the Microbiome conference will focus on the latest approaches to study and treat the wide-range of microbial associated diseases, integrating the disciplines of clinical research, microbiology, immunology, ecology, bioinformatics and genomics. The integration of a wide variety of disciplines will promote new interactions seldom achieved at other microbiome meetings. This meeting will have a specific focus on young investigators and trainees to facilitate the scientific interactions necessary to grow this field and develop novel clinical and experimental approaches, diagnostics and therapies.